AIDS ANTIVIRAL PLANT DITERPENES

Atisane and kaurane diterpenes have been isolated from extracts of two trees from tropical rainforests, Homalanthus acuminatus and Chrysobalanus icaco. One compound from each skeletal type was marginally active; three of the isolates are novel compounds. Some insight has been gained regarding structural features important for the bioactivity. The isolates have been used as templates for installing and testing a variety of 2D-NMR experiments.